Structural and Mechanistic Bases for Ligand Specificity of α1-Adrenergic Receptors

PROJECT SUMMARY/ABSTRACT
α1-adrenergic receptors (ARs) are G-protein-coupled receptors (GPCRs) that play a critical role in regulating
various physiological functions and are implicated in pathological conditions, including heart failure and
Alzheimer’s disease. However, the precise roles of the three α1-AR subtypes, including α1A, α1B, and α1D,
remain poorly understood, largely due to the limited availability of subtype-selective ligands that enable
targeted activation for individual study. Our research program aims to address these significant gaps by
providing structural and mechanistic insights into the ligand specificity of α1-ARs through the use of cryo-
electron microscopy (cryo-EM), combined with biochemical and cellular studies. The long-term goal is to
develop highly selective ligands that exhibit subtype specificity, thereby facilitating a comprehensive
understanding of the distinct physiological roles of each subtype and supporting the development of novel
therapeutics targeting each subtype. Our research will focus on two categories of ligands: agonists and
positive allosteric modulators (PAMs). Agonists bind to the orthosteric binding site of the receptor to activate it,
while PAMs bind to an alternative site to enhance the affinity and efficacy of agonists. Currently, there are only
three α1A-AR selective agonists and one α1A-AR selective PAM available for the entire α1-AR family, with no
selective agonists or PAMs identified for α1B-AR or α1D-AR. A major challenge in developing subtype-selective
ligands is the absence of active state structures of α1-ARs. The first active state structure of α1A-AR was
determined by my postdoctoral work in 2023, alongside similar efforts from another group. To date, no active
state structures of the α1B or α1D subtypes have been reported. My independent research program at
Binghamton University will leverage cryo-EM to generate structural frameworks for understanding the ligand
specificity of α1-ARs. We will determine cryo-EM structures of the three α1-AR subtypes bound to non-selective
endogenous agonists, as well as selective agonists and PAMs. Through systematic structural comparisons, we
aim to identify key residues and ligand functional groups that are critical for subtype specificity. Additionally, we
will validate the roles of these identified residues through mutational and functional studies. This research
program builds upon my extensive experience with GPCR structural and mechanistic studies, as evidenced by
my recent publications and preliminary data described in the Research Strategy. My research group has
established the necessary knowledge, techniques, and tools to successfully execute our research program.
Our findings will pave the way for the structure-based design of novel subtype-selective agonists and PAMs
and contribute to addressing key gaps in understanding the physiological and pathological roles of individual
α1-AR subtypes.

Public health relevance
PROJECT NARRATIVE Our research program focuses on α1-adrenergic receptors (ARs), which are essential for various physiological functions and are associated with conditions such as heart failure and Alzheimer’s disease. By employing cryo- electron microscopy and functional studies, we aim to elucidate the ligand specificity of the three α1-AR subtypes, including both agonists and positive allosteric modulators (PAMs). This research will provide a structural and mechanistic foundation for the development of novel agonists and PAMs targeting specific α1-AR subtypes, while also contributing to addressing significant gaps in our understanding of their distinct roles.